Development and Maintenance of RepeatMasker and RepeatModeler

Project Summary
Mammalian and most other eukaryotic genomes contain a large number of interspersed repeats (IRs), most of
which are copies of transposable elements (TEs) at varying levels of decay. Their presence complicates many
genome sequence analyses, but their accurate identification in an early analysis stage can reduce these
complications. In addition to their pervasiveness, over the last decades the research community has become
widely familiar with their enormous impact on genome activity and evolution.
Every species has been exposed to a unique, complex set of TEs leaving recognizable copies from as long
ago as 300 million years to as recently as the present day. These TEs are uncovered and reconstructed by de
novo discovery methods, often by our RepeatModeler tool, while their copies are then annotated by our
RepeatMasker software. De novo methods can create TE libraries at a reasonable pace, but the product is far
from the desired quality that can be reached by hand curation. With the recent explosive growth in sequenced
species, these finishing steps, perhaps never fully automatable, now form a severe bottleneck in genome
analyses due to a lack of manpower and expertise, while the results, especially when produced by different
methods from different research groups, lack consistency and suffer from redundancy. Furthermore, the
annotation of genomes for which high-quality libraries have been created is not keeping up with library
improvements due to the computational burden of re-analysis.
In this proposal, we describe a plan to refactor RepeatMasker by generalizing and improving TE alignment
adjudication, switching to a family-centric search strategy with support for incremental re-analysis, improving
annotation reporting and supporting cluster environments. Responding to the need for improved methods for
automated TE library generation we propose making significant changes to RepeatModeler’s core discovery
algorithms, develop a novel model extension tool, and. In addition, we will extend our novel methods for
exploiting multi-species alignments and ancestral reconstructions and utilize them to build a comprehensive
mammalian TE library.

Public health relevance
Project Narrative Most of the vertebrate genome finds its ultimate origin in transposable elements, once best known as prototypical selfish DNA, and their annotation is crucial for genome sequence analysis and our understanding of their unrivaled impact on genome biology and evolution. Their de novo discovery and description has become a bottleneck in the genome analysis of the thousands of new species sequenced every year. In this proposal, we describe a plan to make foundational changes to the way RepeatMasker adjudicates TE alignments and assigns confidence to annotations, and present two feasible and novel paths to improving the generation of new TE libraries through the use of multi-species genome alignments and ancestral reconstructions and core algorithmic changes to our RepeatModeler discovery tool.